Understanding how appropriate apoptotic cell degradation ensures lung homeostasis

Project Summary
Efferocytosis, the phagocytic uptake of apoptotic cells (ACs), is a critical homeostatic mechanism that
regulates all metazoan tissues. These ACs, produced daily during tissue turnover, are cleared by professional
phagocytes (typically tissue-resident macrophages) in a sequence that first involves the sensing of an AC,
followed by the engulfment and digestion of that AC. Digestion of ACs is potentially hazardous, as the AC
contains dangerous biomass that a phagocyte must handle in order to maintain cellular and tissue homeostasis.
For example, in atherosclerosis, aberrant macrophage lipid digestion causes “foamy cell” build-up which
prevents subsequent efferocytosis, causing plaque formation and inflammatory necrosis. In lung granulomatous
and lysosomal storage diseases, macrophages feature undigested ACs. Critically, these diseases often implicate
lysosome-associated proteins that are often uniquely expressed in tissue-resident macrophages. As a result, our
lab has proposed that the failure to appropriately digest ACs (FAD) during efferocytosis is a main driver of
pathogenesis. However, the cellular mechanisms behind FAD have not been fully characterized.
To understand how FAD impacts lung homeostasis, we will target lysosome-associated proteins in
alveolar macrophages implicated in pulmonary diseases (Aim 1). We will utilize our novel, highly resolved ex
vivo efferocytosis assay that better-represents physiological tissue turnover to identify candidate genes that
disrupt AC digestion. We will then investigate putative AC digestion genes using a medium throughput assay
that allows us to rapidly generate and study the functional and physiological consequences of gene deletions in
alveolar macrophages in vivo. In parallel, we will use novel fluorescence reporters to visualize organelle
dynamics during efferocytosis in order to understand how FAD impacts cellular homeostasis (Aim 2). As AC-
derived biomass must be shuttled through solute transport carriers to organelles such as the ER and
mitochondria, we hypothesize that FAD impacts cellular homeostasis by impairing metabolite transport between
organelles. As part of this aim, we will visualize contact site formation and duration between the phagolysosome
(site of AC digestion) and the ER/mitochondria. To test our hypothesis, we will quantify these contact sites during
healthy efferocytosis and in macrophages with digestion deficiency to assess whether FAD disrupts cellular
organelle homeostasis.
Collectively, these studies will probe FAD in both cellular and tissue (lung) settings. These studies will
demonstrate a direct link between lysosome-associated proteins and FAD in promoting lung pathogenesis.
Additionally, this work will explore the mechanisms of cellular dysfunction during aberrant AC digestion in
macrophages and provide novel visualizations of subcellular organelle dynamics during real-time efferocytosis.
The completion of these studies will provide tools to dissect FAD during efferocytosis and highlight the
importance of AC digestion in maintaining tissue, especially lung, homeostasis.

Public health relevance
Project Narrative Efferocytosis, the phagocytic engulfment of apoptotic cells, maintains tissue homeostasis, yet improper handling of apoptotic cells post-engulfment is a previously underappreciated contributor to the pathogenesis of a panoply of diseases. This proposal will reveal the cellular mechanisms that underlie how macrophages, the body’s professional phagocyte, handle apoptotic material in both healthy and disease contexts. Understanding apoptotic cell digestion is especially important as the insights obtained will provide mechanistic evidence for the etiology of inflammatory diseases of the lung.